Beta-cell self-antigen recognition by diabetogenic CD8 T cells

Project summary
Type 1 diabetes (T1D) is a result of T-cell mediated destruction of insulin-producing beta-cells in the pancreatic
islets. Autoreactive CD8 T cells are required in this “mistaken” immune response but how they drive disease is
ill-defined. There are two key time points during the life of autoreactive T cells closely related to disease,
namely, their creation in the thymus and activation in the periphery. The former fails to eliminate the potentially
pathogenic T cells whereas the latter allows them to travel to and stay in the target tissue to mediate damage.
Both events are strictly dependent on recognition of beta-cell self-antigens. However, little is known about how
diabetogenic CD8 T cells recognize beta-cell antigens. We have over the years studied T cell antigen
recognition using novel ultrasensitive two-dimensional (2D) force-based methods, showing 2D TCR affinity and
bond lifetime with peptide:MHC as two main kinetics parameters that dictate thymocyte selection outcome and
T cell effector functions. The current project aims to use these 2D methods to define binding kinetics of beta-
cell antigen recognition by diabetogenic CD8 T cells in the context of their thymic development, peripheral
effector function, and T1D pathogenesis. Our preliminary data show that CD8 T cells form weak bonds with
beta-cell antigens during thymocyte selection but increase bond strength upon activation. Such change of self-
reactivity is mediated by coreceptor CD8. In contrast, the same parameters did not change for foreign antigen
recognition. These data support our central hypothesis that, in autoimmune diabetes, CD8 fundamentally alters
self-antigen recognition through modulation of TCR binding kinetics, thereby endowing CD8 T cells with
heightened self-reactivity that overcomes self-tolerance to mediate beta-cell destruction. We propose two
specific aims to test this hypothesis. In Aim1, we will define 2D affinity and bond lifetime of beta-cell antigen
recognition by CD8 T cells. We hypothesize that diabetogenic CD8 T cells, even at a single clonal level, are
highly adaptive in antigen recognition such that they use weak binding kinetics to survive central and peripheral
tolerance but greatly increase self-reactivity to precipitate disease. We will use a panel of monoclonal
diabetogenic TCR cell clones based on the NOD mouse model of T1D to systemically characterize beta-cell
antigen recognition during diabetogenic CD8 T cell thymocyte selection and peripheral activation and
investigate a causal relationship between plasticity of beta-cell antigen recognition and autoimmune diabetes.
In Aim2, we will elucidate the underlying mechanisms of beta-cell antigen recognition. We hypothesize that
plasticity of beta-cell antigen recognition by diabetogenic CD8 T cells is due to CD8 binding kinetics with MHC.
We will first define the role of CD8 in the overall beta-cell antigen recognition. We will then test a sub-
hypothesis that unique patterns of CD8 glycosylation determine adaptability of CD8 binding kinetics by T cell
glycan profiling, phenotyping, and single cell transcriptomic analysis.

Public health relevance
PROJECT NARRATIVE The current project investigates the role of diabetogenic CD8 T cells in autoimmune type I diabetes (T1D) from the perspective of beta-cell self-antigen recognition. This will be undertaken by novel biophysical single cell/single molecule methods in combination with cutting edge biological/immunological assays to elucidate the underlying molecular mechanisms. This will provide mechanistic understanding of beta-sell self-recognition (compared to normal foreign-recognition) and offer new insights for future direct therapeutical targeting of diabetogenic CD8 T cells.